Computationally modeling the failure of effort to become a secondary reinforcer in schizophrenia

PROJECT SUMMARY In the United States, psychotic disorders (PDs) are the leading medical cause of functional disability, resulting in extremely high rates of unemployment and high financial costs to the public healthcare system. Due to the role that negative symptoms play in functional disability in PDs, it is critical that progress be made in understanding mechanisms leading to negative symptoms. Current theoretical models of negative symptoms postulate that dysfunctional cortico-striatal interactions lead to impairments in several aspects of reward processing that prevent PD patients from utilizing decision-making processes needed to perform goal directed behavior. Paramount among these reward processing abnormalities is effort-cost computation. Impaired effort-cost computation has been repeatedly demonstrated in PDs and linked to greater negative symptom severity; however, the processes underlying this association and its ties to real-world functioning are unclear. In the current study, we aim to test the novel hypothesis that negative symptoms and poor functional outcome are associated with the failure of effort to become a secondary reinforcer. There is evidence from studies on animals and humans indicating that if high effort is consistently paired with high reward, this can form a conditioned association, whereby effort itself takes on the status of a secondary reinforcer (i.e., effort itself is learned to have value, even if it is not rewarded). Building upon translational neuroscience paradigms developed in rodents, we will administer a novel effort as a secondary reinforcer task to outpatients with PDs (n = 45) and healthy controls (n = 45). The task consists of four phases: 1) difficulty scaling: participants will perform 4 cognitive tasks (anagrams, Gabor patches, mental arithmetic, trail making) and a staircase procedure will be used to determine individualized difficulty levels set for low and high effort options utilized in subsequent phases ; 2) baseline: a two-forced choice effort decision-making task will be performed in relation to four cognitive tasks to determine baseline levels of effort avoidance; 3) effort training: in a two- forced choice decision making task, selection of a high effort option will be probabilistically reinforced over several training blocks performed for 3 tasks; 4) test phase: near and far transfer effects of training will be examined for the 3 tasks participants were reinforced to select the high effort option on (near transfer), as well as a novel task they were not trained on (far transfer). In addition to measuring decision-making behavior, pupil dilation will be recorded continuously throughout the four phases as an objective marker of cognitive effort. A novel computational model will be applied to evaluate mechanisms involved with the failure of effort to become a secondary reinforcer, which evaluates reward sensitivity, learning rate, and effort cost. We will explore the novel hypothesis that avolition is associated with the failure of effort to become a secondary reinforcer, and that modeling components associated with learning rate, effort cost, and reward sensitivity will predict this deficit. Completing this R21 will provide a new mechanistic understanding of avolition.

Public health relevance
PROJECT NARRATIVE In the United States, psychotic disorders are the leading cause of medical disability, resulting in extremely high rates of unemployment and high financial costs to the public healthcare system. Due to the critical role that negative symptoms plays in functional disability in psychotic disorders, it is critical that progress be made in understanding mechanisms leading to negative symptoms, in order to develop effective treatments. The goal of the current project is to test a novel theory about the mechanisms of negative symptoms as resulting from a failure of effort to become a secondary reinforcer.